R01-Signature Project: A hybrid implementation trial testing strategies to scale an evidence-based weight management program for persons with serious mental illness

Obesity is highly prevalent among people with serious mental illness (SMI), and through its effects on other
cardiovascular disease (CVD) risk factors, represents a principal cause of preventable death in this population.
There is an urgent need to scale behavioral interventions that can effectively address obesity in persons with
SMI, however, rigorous testing of implementation strategies is needed to address the numerous system-,
organizational-, and individual-level barriers that hinder their widespread adoption and sustainment. One such
behavioral intervention, tailored to address this population’s unique needs, demonstrated clinically significant
weight loss in persons with SMI through the NIMH-funded ACHIEVE trial. During the ALACRITY Center’s initial
funding period, our team adapted the ACHIEVE intervention so that it could be delivered by community mental
health staff – resulting in the ACHIEVE-D weight management program – which incorporated implementation
strategies such as training, coaching, and organizational strategy meetings to support intervention delivery.
The pilot showed high levels of staff engagement and client participation, however, there were several barriers
to program sustainment. In the proposed study, we will partner with community mental health organizations in
New Jersey and Delaware, state leaders, and other partners to adapt and test strategies to support the
implementation and sustainment of ACHIEVE-D, including: 1) Replicating Effective Programs (REP), the
foundational implementation strategy that includes ACHIEVE-D program materials, training, and technical
assistance, and 2) an enhanced implementation strategy package with: a) an internal facilitator to support site-
level communication and coordination, leadership for implementation, and a supportive implementation
climate, and b) bi-state learning networks to promote knowledge-sharing, peer influence, skill development,
and high-quality relationships. We will test these multi-level strategies in a cluster-randomized Type 3 hybrid
effectiveness-implementation trial. Our uniquely and highly qualified team propose the following Specific Aims:
1) establish a collaborative partnership with 32 community mental health programs (64 staff implementers and
320 clients participants) in New Jersey and
Delaware and state mental health leadership to plan for ACHIEVE-
D implementation and sustainment, integrating cost planning; 2) determine the effectiveness of the enhanced
implementation strategy package (compared to REP alone) on the uptake and delivery of ACHIEVE-D at six
months; measure implementation from 7 through 12 months; and 3) determine the costs, budget impact, and
cost-effectiveness of deploying REP plus the enhanced implementation strategy package versus “standard”
REP to support scaling and sustainment of ACHIEVE-D. By engaging with partners across two states to test
multi-level strategies to inform implementation, sustainment, and scaling of an evidence-based weight
management program, this study represents a significant step towards advancing our ability to scale effective
interventions that can address obesity and improve cardiovascular health for persons with SMI.